Overcoming primary and secondary resistance in wild-type BRAF melanoma

Project Summary – Project 4

Melanoma is the deadliest form of skin cancer. While significant progress has been made treating melanoma,
drug resistant represents one of the greatest challenges to achieve optimal responses and improve patient
outcomes. Our long-­term goal is to understand mechanisms underlying dysregulated signaling and drug
resistance in melanoma to form the pre-­clinical basis for improved treatment options. In this project, we are
focusing on a clinical unmet need, the treatment of cutaneous melanomas that are wild-­type (WT) for BRAF
(both WT BRAF/WT NRAS and mutant NRAS). MEK-­ERK1/2 signaling is activated in WT BRAF melanoma
but the response to MEK inhibitors is poor. Furthermore, immune checkpoint agents elicit responses in only
30-­40% of cases and patients who are non-­responsive have no effective treatment options. The goals of this
project are to identify drug tolerance mechanisms in subsets of WT BRAF melanomas to provide the basis for
new strategies to improve targeted inhibitor treatments and provide salvage options for melanomas that are
non-­responsive to immune checkpoint agents. Our preliminary data indicate that MEK inhibition triggers a
receptor tyrosine kinase-­mediated adaptive response in WT/WT melanoma. Based on these data, we
hypothesize that the efficacy of MEK inhibitors will be improved with agents targeting either adaptive ErbB3
responses or epigenetic BET/BRD ‘reader’ proteins, as these epigenetic readers regulate multiple receptor
kinase tyrosine kinase and oncogenic pathways associated with drug resistance. We aim to identify and target
mechanisms underlying enhanced activation of the growth factor receptor, ErbB3, in MEK inhibitor-­treated
melanoma. Additionally, we will test the efficacy of BET inhibitor-­based combinations to mitigate
stress/therapy tolerance mechanisms and develop optimal combinatorial approaches to offset drug resistance.
We will primarily focus on WT/WT melanoma but, where possible, extend our observation to mutant NRAS
melanoma. To achieve these goals, we will leverage our unique genetically and clinically annotated models
including in vitro 3D/T cell autologous organoids, immune checkpoint inhibitor-­resistant patient-­derived
xenografts and syngeneic mouse models. Through synergistic interactions with other projects and cores in the
P01, we will identify mechanisms underlying tumor cell intrinsic and stromal-­mediated adaptive responses to
targeted and immune therapy and inform future combinatorial targeted/epigenetic inhibitor strategies that can
be translated into effective treatments. This project meets the NCI mission by conducting research into the
treatment of the deadliest form of skin cancer.

Public health relevance
Project Narrative – Project 4 In Pennsylvania (the state served by our Cancer Centers), the 5 year incidence of melanoma is above the national average and is the fastest rising across cancer types. This proposal aims to address the issue of increased melanoma by providing the preclinical basis for targeted inhibitor and epigenetic inhibitor combinations within subsets of genetically- defined wild- type BRAF melanoma patients.